Task A49: Diabetic Mouse Models of Melioidosis

This contract provides for the development and standardization of small animal models for infectious diseases, and may include efficacy testing of candidate therapeutic products.